Establishing an in-vivo Sleeping-Beauty Screen to Identify and Characterize Novel Drivers of Melanomagenesis in a Nevi-Prone Zebrafish Model.

Abstract
Melanoma, a deadly cutaneous malignancy, is increasing globally despite treatment advances.
Melanocytic nevi ("moles") are often studied for early diagnosis, but their risk of progressing to
melanoma is low. While BRAFV600E or NRASQ61R mutations are common in both melanomas and nevi,
additional mutations in tumor-suppressor genes are needed for melanoma development. Similar to
human nevi, BRAFV600E and NRASQ61R nevi in zebrafish remain benign. Even in tp53-deficient
BRAFV600E and NRASQ61R fish, only a small percentage of nevi advance to melanoma. These findings
emphasize the robust constraints on nevus growth and the need for cooperative transcriptional changes
for melanocyte transformation. A knowledge gap exists in our understanding of the transcriptional
mechanisms outside of somatic mutations that are necessary for transformation. The Sleeping Beauty
(SB) transposon mutagenesis system has been utilized to identify novel genes associated with
melanoma recurrence. It is unique in comparison to other genetic screens (i.e. CRISPR gRNA) in that
transposon integration allows for gene silencing, activation or expression of truncated transcripts
through an internal promoter within the transposon. We have established two transgenic nevi-prone
zebrafish line, that harbors a germline T2/OncZ transposon, Tg(mitfa-BRAFv600e: T2/OncZ): mitfa-/- and
Tg(mitfa-NRASQ61R: T2/OncZ): mitfa-/-. Introducing plasmids expressing mitfa into melanocyte stem
cells in our transgenic mitfa-/- fish rescues melanocytes, achieved through injection and electroporation
of plasmids carrying the mitfa-promoter driving expression of mitfa, thus inducing nevi formation. While
rescued melanocytes propagate into nevi within 4 weeks, these zebrafish remain melanoma-free for
up to ~1 year. Injecting mitfa-SB100 transposase plasmids into formed nevi at 6 weeks induces SB
mutagenesis and results in transposition of the OncZ transposon, and thus anticipated to accelerate
melanocyte transformation. Sequencing melanomas and control nevi will identify significantly enriched
transposon integration sites and a short list of candidate genes will be identified. The function of such
genes, predicted to be accelerators of melanomagenesis and in the context of both BRAF and NRAS-
induced nevi, will be validated by in vivo and in vitro assays utilizing zebrafish and human melanocyte
cell lines. Our proposal presents a novel in vivo application of the SB system to uncover unique
accelerators of melanomagenesis. This approach combines established zebrafish lines with transgene
electroporation techniques, allowing for precise spatial and temporal control over tumor initiation. We
aim to identify new transcriptional mechanisms underlying nevi transformation, offering critical insights
into melanoma biology and advancing genetic methodologies in cancer research.

Public health relevance
Project Narrative: This study investigates novel gene regulatory networks crucial for melanomagenesis, utilizing the Sleeping-Beauty transposon system to identify accelerators of BRAF- induced and NRAS-induced melanoma. Our project introduces an innovative research methodology, establishing an in vivo cell type-specific screen where oncogenic BRAF or NRAS-positive benign nevi undergo mutagenesis, leading to transformation events. We will identify top candidate genes through targeted sequencing of transposition events and validate these genes both in vivo, using Zebrafish, as well as utilizing human primary melanocyte cell lines.